Development of Catalytic Conjunctive Coupling Reactions

Project Summary. New strategies for constructing chiral organic molecules can have a significant impact on the production of important medicinally-active compounds and organic materials. The proposed research will develop an unprecedented catalytic conjunctive coupling reaction that results in the combination of three readily available simple organic molecules and establishes a product with a two new C- C bonds and a boron-containing stereogenic center. The reactivity manifold described is the first of its kind and it promises to result in the introduction of an array of new reactions to accomplish the stereoselective synthesis of important chiral compounds.

Public health relevance
Project Narrative. Enantiomerically-enriched chiral compounds are important materials in the pharmaceutical industry and have applications in the study of biological processes. The proposed research aims to introduce new processes for the inexpensive, efficient, and selective production of such chiral compounds under the influence of small amounts of specially designed catalysts. In this regards, it can be anticipated that the proposed research will have a significant impact on human healthcare.